Interventions in math learning disabilities: cognitive and neural correlates

Project Abstract
Mathematical learning disabilities (MLD) impact up to 14% of school-aged children, and are linked to high rates
of morbidity and poorer health outcomes making it a significant public health concern requiring
extensive health resources. Designing effective interventions to remediate MLD and identifying the
cognitive and neurobiological features underlying their efficacy are critical steps for addressing the public
health burdens of innumeracy and learning disabilities more broadly. Leveraging a productive, innovative, and
high-impact line of research, we propose to investigate neurocognitive mechanisms underlying response to
intervention (RTI) aimed at remediating core and persistent cognitive impairments in children with MLD.
To achieve this goal, we will use a theoretically-motivated integrated symbolic/non-symbolic (iSNS)
intervention with a randomized controlled design to enhance cross-format mapping between symbolic and
non-symbolic representations of quantities. We will develop innovative computational models to investigate
individual differences in latent cognitive processes, including evidence accumulation, sensitivity to item
difficulty, and performance monitoring, that underlie learning and brain plasticity in children with MLD. Our
central hypotheses are that (1) iSNS will remediate numerical problem-solving deficits and strengthen latent
cognitive processes in children with MLD, and that (2) plasticity of neural representations and
reconfiguration of functional brain circuits and networks will contribute to learning, retention, and transfer
in children with MLD. Crucially, building on innovative systems neuroscience approaches, we will leverage
novel computational tools and quantitative network analysis of functional brain circuits linking visuospatial
attention, cognitive control, and memory formation systems to advance foundational knowledge of the
neurocognitive mechanisms underlying RTI in children with MLD. Findings from our novel approach and
neurocognitive models will have major implications for informing the etiology of MLD, the neurobiology of
learning disabilities more generally, and the neurocognitive basis of individual differences in RTI.
Findings will also provide new insights into individual differences in learning, with broad consequences for
optimizing learning in all children. More broadly, our proposed studies will provide a deeper understanding of
dynamic neurocognitive processes underlying learning, retention and transfer (generalization) in children
with learning disabilities.

Public health relevance
Project Narrative Mathematical learning disabilities (MLD) affect up to 14% of school-age children, leading to adverse life-long consequences for socio-economic well-being, health, and life expectancy. The proposed studies will use a theoretically motivated cognitive intervention, novel computational tools, and brain network models to provide important new knowledge about cognitive and brain mechanisms underlying remediation of poor numerical skills in children with MLD. Findings from our studies will identify the mechanisms by which cognitive intervention enhances foundational cognitive skills and learning in children with MLD and determine sources of individual differences in learning in RTI, with broad implications for optimizing learning in children with learning disabilities and neurodevelopmental disorders more broadly.